The Role of mtDNA/ZBP1 in Retinal Neurodegeneration

Project title: The role of mtDNA/ZBP1 in retinal neurodegeneration
SUMMARY
Glaucoma is the second leading cause of irreversible blindness worldwide. It is characterized by progressive
retinal ganglion cell (RGC) degeneration. Glaucoma is strongly associated with increased intraocular pressure
(IOP) and IOP is the only treatable target for glaucoma. However, lowering IOP does not always stop the
progression of glaucoma. It is urgent to identify other mechanisms of neuropathy in glaucoma for therapeutic
intervention. Mitochondrial DNA (mtDNA) is very vulnerable to oxidative stress-induced damage and is
released into the cytoplasm or extracellular environment. Given that mtDNA shares several characteristics with
bacterial DNA including small size, multiple copies and methylation status, the released mtDNA can activate
pathways historically reserved for pathogen recognition. ZBP1 senses double-stranded DNA and RNA that
adopt, or are prone to adopt, a left-handed Z-form double-helical structure. It plays an important role in innate
immune response by binding to viral nucleic acids, leading to the production of type I interferons and other
inflammatory responses crucial in controlling viral infections and triggering death of infected cells. This
application, led by muti-PIs possessing unique complimentary expertise, will test the hypothesis that damaged
mtDNA acts as a crucial active signal in RGC degeneration during glaucoma by binding to the
intracellular DNA/RNA sensor ZBP1. Novel ZBP1 conditional knockout or overexpression mice, in vivo
tracking of CD63+ extracellular vesicles (EVs), and comprehensive in vitro mechanistic studies will be
integrated to test this hypothesis. Completion of the proposed studies will provide important new knowledge
about the damaged mtDNA, which acts as a novel immune factor, in induction of intrinsic signaling in RGCs
and in the regulation of microglial activation by binding to a novel intracellular DNA/RNA sensor ZBP1. These
mechanisms may guide the development of novel therapies for glaucoma. This proposal is in line with Vision
for the Future in the NEI Strategic Plan, Areas of Emphasis “Immune System and Eye Health”: 1) investigate
neurobiology roles for immune factors that challenge orthodoxy and examine whether these “immune” factors
are playing nontraditional roles for vision function; 2) understand the role of resident retinal cells in promoting
immune homeostasis.

Public health relevance
NARRATIVE Mitochondrial DNA (mtDNA) is very vulnerable to oxidative stress-induced damage and is released into the cytoplasm or extracellular environment. Our studies will investigate a novel mechanism by which this damaged mtDNA actively contributes to glaucomatous neurodegeneration through interacting with a novel intracellular DNA/RNA sensor ZBP1.